DEVELOPMENT OF AN INTRANASAL VACCINE AGAINST GONORRHEA

To support the advanced development of candidate products for use following the intentional release of or in response to naturally occurring outbreaks of infectious diseases or emerging infectious diseases. This contract may support formulation and manufacture of the individual vaccine components, as well as stability testing, nonclinical immunogenicity and efficacy testing in animal models, IND enabling GLP toxicology, submission of an IND and clinical safety and efficacy evaluation.